Core B: Reagent/Service Core

Core B Summary
The three research projects that comprise this Program Project are all focused on understanding molecular
and cellular events and mechanisms leading to bladder tumorigenesis of both major bladder cancer (BC)
variants and molecular subtypes. In addition to the intellectual and experimental synergies that link the
individual projects into a cohesive program, each of the three proposed research plans all depend upon a
common set of critical reagents and services made available on a continuous basis for their success. These
include but are not limited to a set of cultured cell lines that represent different grades and stages of major BC
variants and molecular subtypes, unique mouse models of bladder cancer developed/used by project leaders
Dr. Wu, Dr. Tang and Dr. Huang, nucleic acid reagents, antibodies and cDNA constructs. Obviously, it would
not make sense, nor would it be an efficient use of time, money, and resources for each laboratory to
independently generate, procure, characterize, and maintain all these reagents. Instead, we have established
a centralized Reagent and Service Core, one of whose purposes is to serve as a central repository for key
reagents and provide a central supply for these important research tools that can be shared by all involved in
this Program Project. In addition to the cost-effectiveness, this approach offers the advantage of ensuring the
quality of these shared reagents across the individual projects. Providing supplies of cell lines, mouse tissues
and animal models from a centralized core eliminates variability in reagent handling, facilitating data
comparison amongst the three individual projects. Furthermore, it promotes additional interactions among the
project directors and guards against accidental loss of invaluable reagents in emergency situations such as
power outages (which we last experienced in 2012 during Sandy Superstorm). Finally, the Core B will also
provide pathology and statistical support for the individual projects. The specific aims of the Core are: i) To
maintain a centralized supply and distribute a common core set of reagents vital to support the research efforts
of individual component projects; ii) To collect mouse specimens and provide the necessary pathology support
service; and iii) To provide dedicated statistical support. Success of this Core will be an essential factor for the
studies that have been proposed in this program project.

Public health relevance
Narrative: This Program Project seeks to understand the mechanisms involved in bladder tumorigenesis leading to different types of bladder cancer. The three projects will use a common set of reagents and services. The Core bundles these critical reagents and services together and serves as a central clearinghouse, ensuring their timely, cost-effective distribution, which will directly facilitate the success of this Program Project. OMB No. 0925-0001/0002 (Rev. 03/16 Approved Through 10/31/2018) Page Continuation Format Page